A digital health parent coaching intervention to improve neurodevelopmental outcomes for young childhood cancer survivors in underserved communities

PROJECT SUMMARY: There are almost half a million childhood cancer survivors in the United States. Over
two-thirds of survivors will develop at least one late effect. Young childhood cancer survivors (YCCS; age at
diagnosis <7 years) are at the highest risk for developing neurocognitive late effects, given their developmental
vulnerability and absence from early education. YCCS miss critical opportunities to develop foundational
school readiness skills, including preacademic, social-emotional, and self-regulatory skills. Neurocognitive risk
is exacerbated for YCCS living in rural and Appalachian areas, who are at elevated risk due to poverty and
distance from specialty care. Digital health interventions (DHIs) targeting positive parenting skills show promise
in promoting neurodevelopmental outcomes in other neurologically vulnerable groups. The proposed research
is the first to co-design a positive parenting DHI for YCCS (3-6 years), called Preparing for Life and Academics
for Young survivors (PLAY) program, to improve their neurodevelopmental trajectory. Following the ORBIT
model phases, PLAY has been adapted in partnership with caregivers and oncology healthcare providers from
parent-coaching DHIs developed by the mentoring team. PLAY involves 6 self-directed web-modules and 8
virtual coaching sessions for caregivers of YCCS (Phase Ia). The rationale and central hypothesis for this
project is that PLAY will improve parent-child interactions and reduce parenting stress, which will lead to
improvements in child school readiness, or prevent future declines.68,71 In Aim 1, the research team will
iteratively refine the PLAY program through rapid cycle testing (Phase 1b) until three families sequentially
endorse above-average usability, feasibility, and acceptability, or until 15 families have completed the
intervention. In Aim 2, a single arm trial (Phase IIa) will be conducted with 15 families to evaluate the
feasibility, acceptability, and proof-of-concept of the refined PLAY program in improving (or maintaining at
normative levels) observed positive parenting skills, parenting stress, and school readiness at 3-and-6 month
follow ups. In Aim 3, a feasibility trial (Phase IIb) will be conducted by randomizing families to either PLAY or
an internet resource comparison group (n = 15 per group) to determine acceptability of randomization and
retention. With the guidance of an exceptional mentorship team, the K08 candidate, Dr. Moscato, will acquire
training in: 1) mixed-methods assessment approaches and intervention strategies for young children, 2)
community-engaged research with rural and Appalachian populations, 3) iterative digital health co-design and
refinement, and 4) the design, conduct, and analysis of behavioral trials based on the ORBIT model. This
training will facilitate Dr. Moscato’s long-term goal to become an independent clinician-scientist focused on
developing equitable DHI for childhood cancer survivors. This K08 proposal will provide preliminary data and
the expertise needed to conduct a large scale RCT. The ultimate goal is to inform culturally responsive,
accessible psychosocial care that enhances quality of life across the lifespan for childhood cancer survivors.

Public health relevance
PROJECT NARRATIVE As more young children survive cancer, they are at risk for substantial late effects from treatment, which lead to a lifetime of healthcare costs, educational delays, and significant public health burden. Given the lack of accessible and tailored early interventions, this study will engage caregivers and healthcare providers in the co-design of a culturally responsive digital health parent coaching intervention to optimize long-term neurodevelopmental and academic outcomes for young childhood cancer survivors and inform more effective supportive care. This is aligned with the NIH’s mission to reduce the burdens of illness and disability, and NCI’s mission to help all people live longer and healthier lives.